A critical forebrain-brainstem circuit contributes to the adaptive and maladaptive cardiorespiratory responses to hypoxia

Chronic intermittent Hx (CIH), a hallmark of obstructive sleep apnea and many other diseases, leads to a long-
term increase in the strength of the peripheral chemoreflex (PCR). An enhanced PCR subsequently increases
sympathetic nerve activity (SNA), leading to hypertension even in wakefulness, a major contributing factor to
downstream cardiovascular diseases such as heart failure and heart failure, leading killers of Americans. Orexin
neurons in the hypothalamus have high activity in wakefulness and project to corticotropin-releasing hormone
(CRH) neurons in the paraventricular nucleus of the hypothalamus (PVN), a nucleus known to facilitate the PCR
via its projections to the nucleus of the solitary tract (nTS). The overarching hypothesis driving this research
is that neuronal circuit comprised of orexin neurons, CRH neurons in the PVN, and nTS neurons (orexin-CRH-
nTS) facilitates the PCR and contributes to the hypertension that follows CIH. We will use an integrative approach
utilizing an array of chemogenetic and in vitro techniques to resolve how the orexin-CRH-nTS enhances the PCR
and contributes to the hypertension that follows CIH.
Specific Aim 1: Does an orexin-CRH-nTS neural circuit facilitate the adaptive peripheral chemoreflex
responses to Hx in the active phase, even in the absence of carotid body inputs? Our novel hypothesis is
that the circuit increases the strength of the reflex, especially in the active phase and independently of
chemoafferent inputs.
Specific Aim 2: Does the orexin-CRH-nTS circuit contribute to sympathoexcitation and hypertension
related to CIH, and is this effect dampened by estrogen? Our novel hypothesis is that CIH activates the
orexin-CRH-nTS in a maladaptive fashion that leads to sympathoexcitation and hypertension. Through an
inhibitory effect on orexin neurons, estrogen mitigates the excitatory influence of CIH on the activity of the circuit.
CIH leads to increased peripheral chemoreflex sensitivity and hypertension, a major health problem as it leads
to multiple cardiovascular diseases that are leading killers of Americans. These studies interrogate a
hypothalamic-brainstem neural circuit (orexin-PVN-nTS) that facilitates the peripheral chemoreflex and thus the
maladaptive cardiovascular responses to CIH. They provide the foundation for strategies targeting the
hypothalamus to alleviate hypertension in patients experiencing CIH, as well as the initial insight into potential
sex differences in maladaptive cardiovascular responses to CIH that have an origin in the hypothalamus.

Public health relevance
Millions of Americans suffer from diseases associated with chronic intermittent hypoxia (e.g., obstructive sleep apnea) which leads to increased sympathetic nervous system activity, hypertension and cardiovascular diseases due to enhanced activity within the peripheral chemoreflex. This project will reveal a hypothalamic-brainstem circuit that is activated by chronic intermittent hypoxia and thus contributes to the increased peripheral chemoreflex and associated cardiovascular diseases that are the leading killers of Americans.